Three-dimensional mapping and modeling of combinatorial interactions underlying biomolecular condensates in olfactory neurons

Summary:
Gene regulation is controlled by the dynamic localization of numerous regulatory factors to precise
nuclear targets. Classic diffusion and affinity models alone cannot explain various aspects of how
these processes occur, and growing observations suggest that regulation of gene expression is
not a linear process that simply reflect the number of regulators and targets in a cell. Recently,
spatial organization of regulatory molecules via formation of biomolecular condensates (BMCs)
has emerged as a likely explanation for the non-linear regulation of gene expression. However,
the functional roles of most condensates remain largely unknown because we lack methods to
simultaneously measure the many different protein and RNA regulators that bind DNA, their 3D
structural interactions in the nucleus, and gene expression within the same individual cell.
To overcome this challenge, we will develop an integrative new framework consisting of cutting
edge molecular and spatial measurements of DNA, RNA, and proteins within single cells
combined with a novel machine learning approach to identify the critical molecular components
required for organization of large, interconnected molecular interaction networks within BMCs.
We will apply these approaches to dissect a long-standing question in neuroscience – how
olfactory neurons stochastically express one, and only one, olfactory receptor gene out of the
>1000 distinct gene located throughout the genome. The transition from polygenic to monogenic
expression coincides with genomic transformations that organize the regulatory landscape of
receptor transcription into competing multi-chromosomal enhancer hubs, localization of numerous
regulatory proteins to distinct hubs, and a critical role for nascent receptor mRNA concentration
in symmetry breaking between distinct hubs.
The overall objective of this work is to develop generalized frameworks for measuring BMCs and
for understanding and predicting relationships and causal components within them, as well as a
detailed characterization of a foundational neuroscience model. We will accomplish this via the
following Specific Aims: (1) Define the spatial and molecular composition and dynamics of BMCs
within olfactory neurons, (2) Formulate a neural network model to identify critical nodes for BMC
organization and function, (3) Validate the functional role of predicted causal “nodes” in olfactory
receptor regulation. Our research team, with collective expertise in molecular mapping,
computational biology, and olfactory system research, is uniquely positioned to address these
questions.

Public health relevance
Narra�ve: The integration of our novel experimental and computational frameworks promises not only to elucidate the role of biomolecular condensates in olfactory receptor gene regulation, but also to provide a fundamental new framework for studying biomolecular condensates. The anticipated outcomes will significantly impact our understanding of how gene expression is regulated and has the potential to transform our approach to studying biomolecular condensates and related regulatory mechanisms across a broad range of biological systems.